ONTRIAL: AI-DRIVEN AND EMR INTEGRATED CLINICAL TRIAL RECRUITMENT TOOL USED BY CLINICAL TRIAL AND PROVIDER TEAMS FOR RECRUITMENT OF DIVERSE POPULATIONS.

Lags, delays, and failures in clinical trial recruitment and enrollment hampers the rate of drug development and medical progress. The work proposed in this contract submission addresses clinic-facing challenges in clinical trial recruitment. The overall goal of the contract is to build, test, and deploy at the Robert H. Lurie Comprehensive Cancer Center of Northwestern University and it’s community affiliated sites a software tool, OnTrial, that improves provider awareness of patients potentially eligible for trials, clinical trial patient eligibility evaluation workflows, team communication of trial recruitment activities, and tracking of recruitment efforts. OnTrial’s innovation is the scalable, secure, and systematic review of patient medical records which are parsed for trial matching metrics using the same approach and data model for trial criteria parsing. The 1-to-1 structuring of patient and trial data is the fulcrum upon which the innovation rests. In this contract effort, OnTrial will include breast, thoracic, head and neck, lung, gastrointestinal, and genitourinary patients and trials. All patients being seen by participating providers will be systematically considered for trial eligibility without bias. It is expected that OnTrial will significantly improve trial recruitment overall as well as the diversity of trial participants. OnTrial software will be deployed on Vizlitics’ Cancer Insights Platform.